An AI-based behavioral intervention to improve pre-exposure prophylaxis for HIV prevention

HIV continues to disproportionately affect men who have sex with men (MSM), particularly those living in the Ending the HIV Epidemic (EHE) jurisdictions. Despite the proven effectiveness of HIV pre-exposure prophylaxis (PrEP) in preventing HIV infections, its uptake among MSM is notably inadequate, particularly among those living in EHE jurisdictions. Motivational interviewing (MI) has shown effectiveness in encouraging at-risk MSM to adopt PrEP; Integrating the Transtheoretical Model (TTM) into MI enables the assessment of an individual's readiness for change and the delivery of tailored MI sessions. However, its labor-intensive nature, requiring multiple sessions, poses a significant challenge. The potential solution lies in harnessing generative artificial intelligence (AI) to streamline and make MI more accessible. This pilot study aims to leverage AI technology to overcome the labor-intensive aspects of MI, potentially reaching a broader audience simultaneously. In the study, we aim to tailor, refine, and test an AI-based Chatbot called CHIA (Chatbot for HIV Prevention and Action) with MI techniques to promote HIV PrEP among MSM living in the EHE jurisdictions. The CHIA will be tailored and fine-tuned based on the latest Chat Generative Pre-Trained Transformer (ChatGPT) model to employ MI techniques to assess HIV risk and TTM stage, provide stage appropriate education, and motivate individuals to initiate PrEP (specific aim [SA] 1). In an open pilot trial involving 15 participants aged 18 years or older recruited via various social media platforms, we will rigorously evaluate the CHIA's accuracy, participant satisfaction, and responsiveness to individuals’ needs with refinement made as indicated in SA2. The refined CHIA will subsequently undergo evaluation in a pilot randomized controlled trial (SA3) to assess its acceptability, feasibility, and preliminary efficacy in promoting PrEP uptake. We will randomly assign participants to the intervention (at least 60 minutes of engagement with CHIA in two or more sessions within two weeks of enrollment, N=50) or the control arms (standard of care by research staff: risk assessment, PrEP education, risk reduction counseling, and PrEP referral if interested, N=50) with a 1:1 ratio. Primary outcomes include prescription receipt, pharmacy filling, and drug concentration levels, providing definitive markers of PrEP uptake. The proposed pilot study has the potential to leverage the power of emerging AI technologies to incorporate MI into HIV prevention and PrEP promotion. If successful, the proposed pilot study will help facilitate AI in the field of HIV prevention as well as reduce HIV incidence among MSM.

Public health relevance
PROJECT NARRATIVE This pilot study aims to tailor, refine, and assess the CHIA (Chatbot for HIV Prevention and Action), an AI- based Chatbot with motivational interviewing (MI) techniques to promote HIV pre-exposure prophylaxis (PrEP) uptake among men who have sex with men (MSM) living in the Ending the HIV Epidemic (EHE) jurisdictions. Utilizing the latest Chat Generative Pre-Trained Transformer (ChatGPT) Model, CHIA will evaluate HIV risk and readiness of change based on the Transtheoretical Model (TTM), provide personalized education, conduct stage-appropriate MI for PrEP promotion, and aid in linking individuals to PrEP care. Following iterative refinement in an open pilot trial, a subsequent pilot randomized controlled trial will evaluate CHIA’s acceptability, feasibility, and preliminary efficacy in promoting PrEP uptake when compared to standard of care among MSM, with outcomes including receiving a prescription, pharmacy filling, and drug concentration levels.